Relative Immunological Effectiveness (RIE) of Carbon Ion Radiation Therapy for Pancreatic Cancer

Abstract
Pancreatic cancer is the leading cause of cancer-related death with less than 5% (5-year) survival rate with
current treatment regimen involving chemo-radiation therapy. Almost all patients with pancreatic cancer
eventually develop metastatic disease with poor prognosis for survival. There remains a significant opportunity
for breakthrough strategies to improve the quality of life and outcomes for pancreatic cancer patients. Recent
studies have shown some success with proton therapy and the interest in proton RT has grown progressively
with increasing evidence indicating substantial benefit over photons (XRT). The success of proton therapy relies
on precise delivery of high dose in tumor tissue, sparing normal tissue due to the nature of its Bragg’s peak,
while maintaining similar therapeutic advantages as XRT. Carbon ion radiation therapy (CIRT) offers steep
Bragg’s peak and less scatter but also higher LET (Linear Energy Transfer), resulting in greater ionizing events
and greater biological damage. We hypothesize that greater complex DNA damage also defined as relative
biological effect (RBE) of CIRT can induce stronger immune response. In the current proposal, we are testing
the hypothesis that high-LET CIRT has unique ability of enhancing tumor immune response, when applied alone
or combine with other immunotherapeutic agents. Our goal is to determine the immunomodulation effectiveness
of CIRT compared to XRT in pancreatic cancer mouse model. We will test the effect of high LET-CIRT on tumor
cells as well as the immune cells at local and systemic level. We will correlate biological end points such as DNA
double strand breaks (DSB), complex DNA damage and clonogenic survival in XRT/CIRT-irradiated cells with
their ability to induce immune response under aim 1. We will also determine whether HDAC inhibition enhances
antigen presentation by pancreatic tumor cells in aim 2. Under aim 3, we will enhance the efficacy of CIRT by
reprogramming tumor microenvironment (TME) using concurrent treatment with check point inhibitors and
antigen presentation activators.
Relevance. Successful completion of these studies could establish the significance and help us design unique
combination therapy of immunotherapy with CIRT for solid tumors.

Public health relevance
NARRATIVE Carbon ion radiotherapy (CIRT) is currently the world’s most advanced radiotherapeutic technique; compared with traditional photon radiotherapy, it has unique physical characteristics and biological advantages. It is better at protecting the normal tissue and organs surrounding the tumor and is more effective at killing tumor tissue and particularly tumor cells that can normally resist photon radiotherapy. While X-ray therapy using photons travel through our body, carbon ion is like a dart. It stops at a depth inside our body and releases all its energy in the form of a peak dose in the tumor. Since the track stops at a depth, the particle beam does not go through the body, thereby causing less harm to surrounding normal tissues. Since the particles cause DNA damage and the irradiated cells behave as if they are infected by a DNA virus and increase the body’s anti-viral defense system. We are looking into possible immune activating role of CIRT that possibly helps us fight cancer. We are going to look into the immunological consequences of CIRT for the treatment of pancreatic cancer, a devastating disease where we are losing our battle. Our goal is to determine the immunological effectiveness of CIRT compared to XRT (X rays) in mouse pancreatic cancer models for the treatment of both primary and metastatic cancer. If successful, this will allow us to bring a very sophisticated therapy for our cancer patients.